Enhancing the Utility of the Trend-in-Trend Research Design

Patients, clinicians, and policymakers often need valid information about the real-world effects of drugs and other
exposures for which there have been pronounced time-trends in use. For example, the rapid growth in the use of rofecoxib
in the early 2000s and of exogenous testosterone from 2000–2013 was accompanied by an urgent need for knowledge
about the cardiovascular effects of those drugs. Randomized trials seldom enroll a sufficient number of subjects, or follow
them long enough, to examine associations with rare outcomes. Therefore, non-randomized studies are needed, even
though they are susceptible to unmeasured confounding and other forms of bias. To address these limitations of available
epidemiologic designs, we recently introduced the trend-in-trend design: a novel, hybrid epidemiologic-ecologic research
design that is applicable when there is a prominent trend in the use of the study exposure. Substantial additional
development is needed to realize the full public health impact of the trend-in-trend research design. Areas in most need of
development include: evaluation of a sequential analysis extension for real-time post-marketing safety surveillance;
evaluation of machine learning to specify the trend-in-trend design’s underlying cumulative probability of exposure
model; evaluation of dose-response relationships; and evaluation of treatment effect heterogeneity based on baseline
patient characteristics. For each of these methodologic needs, we propose an approach for which we will: 1) assess its
statistical properties, in particular large-sample validity through asymptotics and finite sample statistical power; 2)
evaluate its performance in thorough simulation studies; and 3) proof-test the approach using the known association
between rofecoxib-acute myocardial infarction in healthcare data. Finally, we will apply these developments to the
unresolved and highly important question of the cardiovascular, cerebrovascular, and thromboembolic effects of
exogenous testosterone in men.
This study will have broad scientific, clinical, and public health impact by greatly extending the utility of a novel
epidemiologic research design with demonstrated validity and is applicable to a broad range of exposures with a
prominent trend in use. It will also evaluate the safety of exogenous testosterone, a question of tremendous clinical and
public health importance. Examining the safety of prescription drugs is one enormously important application of this
design that has the potential to benefit many millions of people. As the trend-in-trend design is also applicable to non-drug
exposures that have a pronounced time-trend (e.g., medical procedures, lifestyle factors, environmental exposures, etc.),
its potential impact on the population is even broader.

Public health relevance
This project will enhance the utility of the trend-in-trend research design, a novel hybrid epidemiologic-ecologic design that is applicable to a broad range of exposures with a prominent trend in use. Further, we will leverage these methods developments to study the cardiovascular, cerebrovascular, and thromboembolic safety of exogenous testosterone, unanswered questions of tremendous clinical and public health importance for older adult males.